Institutional Career Development

The UIC Clinical and Translational Sciences (CATS) Scholars Program was initiated in 2009 with the initial NIH
funding for the UIC Center for Clinical and Translational Science (CCTS). Our Program has filled a significant
gap in career development for biomedical research faculty at UIC, championing and creating a new culture of
career mentorship and establishing a vibrant cadre of well-trained and highly successful faculty in clinical and
translational science. Over the past 10 years, the CATS Scholars Program has provided mentorship and career
development for 34 Scholars through both CTSA and institutional support. Our program supports a diverse
group of Scholars who are >60% women, >35% from groups underrepresented in biomedical research, and from
five different health sciences colleges. The overall goal of the CATS Scholars Program is to support the
development of clinical and translational scientists who will engage the community and who will make substantive
research advances that impact patient care. The specific goals of the program are 1) to provide a mentored
career development experience that allows Scholars to develop the NIH/CTSA identified core competencies in
clinical and translational research, 2) to provide Scholars with unique training opportunities that will drive
innovation in research and 3) to systematically evaluate the Program and provide for continuous improvement
and alignment with NIH/CTSA goals of advancing therapeutics, clinical interventions, and behavioral
modifications to improve health. The program is supported by a cadre of more than 40 outstanding mentors who
maintain vibrant and relevant research programs along with a commitment to mentoring. Innovative components
of the program include an institutional commitment to a 3rd year of support for every Scholar, institutional support
for external experiences to enrich Scholar training, extension of program activities to support additional “Affiliate”
Scholars, engagement of former Scholars as mentors and advisors to the program, and a strong interactive
career development program that spans all three Chicago CTSA hubs. Our Scholars benefit greatly from the
core services, educational programs, and capacity of the UIC CCTS, and the utilization of these services has
been instrumental to their growth. The activities of CATS Scholars align with the national CTSA goals of
advancing therapeutics, clinical interventions, and behavioral modifications to improve health, as the Program
Plan includes activities within these themes. The success of our scholars is evidenced by their rapid acquisition
of independent extramural funding and by the continued advancement of Scholars as leaders in clinical and
translational science. The CATS Scholar program, with its inclusive reach, provides a needed and highly valuable
career development resource for clinical and translational science faculty at UIC.

Public health relevance
Project Narrative Not Applicable